Expanded Safety and Preliminary Efficacy of Adjuvant 5-Fluorouracil Following Thermal Ablation to Improve HPV Treatment Outcomes in Women with HIV in Africa

ABSTRACT
Women in low- and middle-income countries (LMICs) shoulder a disproportionate burden of cervical cancer,
accounting for 85% of new cases and 90% of deaths worldwide. Women living with HIV (WWH) -70% of whom
reside in Africa – are at especially high risk, with up to 6-fold increased likelihood of developing cervical cancer
due to higher incidence and persistence of human papillomavirus (HPV) infection. Consequently, cervical
cancer is the leading cause of cancer-related death for WWH in LMICs. Although the World Health
Organization (WHO) recommends thermal ablation for treating cervical precancer, recurrence of cervical
intraepithelial neoplasia grade 2/3 (CIN2/3) in WWH following ablation alone can reach 33% within a year of
treatment. This high recurrence partly stems from thermal ablation’s inability to clear HPV infection in WWH,
which is associated with up to 20-fold risk of CIN2/3 recurrence. This is a significant limitation and calls for
urgent and accessible solutions to improve cervical precancer treatment outcomes in this population. Drawing
on evidence from U.S-based randomized trials and a recent Phase I pilot study in Kenya, we propose to
investigate the use of 5-Fluorouracil (5FU), an affordable, widely available chemotherapeutic agent, as a
patient-administrated intravaginal therapy following thermal ablation to improve HPV treatment outcomes
among WWH in Kenya. While 5FU’s safety and efficacy as a primary and adjuvant cervical precancer
treatment have been demonstrated in high-income countries, no randomized trials have investigated its use as
an adjuvant therapy following thermal ablation among WWH in LMICs, where the disease burden is greatest.
This study will address this gap by conducting a pilot Phase IIa randomized placebo-controlled trial to evaluate
the safety, adherence, and preliminary efficacy of self-administered intravaginal 5-fluorouracil (5FU) following
thermal ablation in HPV-positive WWH. We will enroll 140 WWH in Kenya and randomize them 1:1 to receive
either 5FU or a placebo after undergoing thermal ablation. Our aims are 1) to determine the safety of 5FU,
including its effect on genital HIV viral shedding; 2) to evaluate adherence to the self-administered regimen
using both self-reported data and ultraviolet light inspection of applicators; and 3) to determine preliminary
efficacy by comparing type-specific HPV clearance rates between the two treatment arms at 24 weeks. The
trial builds on a successful Phase I single-arm trial of self-administered 5FU in Kenya and leverages well-
established partnerships with local healthcare facilities, research institutions, and the Ministry of Health (see
letter of support). Findings will inform future Phase IIb or III trials evaluating 5FU as an adjuvant therapy for
preventing CIN2/3 recurrence among WWH in Africa and other resource-limited settings. If proven safe,
effective, and acceptable, self-administered 5FU could offer a widely scalable approach to improve secondary
prevention of cervical cancer for millions of WWH globally, helping to move closer to the global goal of
eliminating this preventable cancer.

Public health relevance
PROJECT NARRATIVE Women living with HIV (WWH), most of whom reside in low- and middle-income countries (LMICs), bear a disproportionate burden of cervical cancer and urgently need effective and accessible prevention strategies. Thermal ablation is the most accessible cervical precancer treatment in LMICs but is limited by unacceptably high recurrence rates among WWH. To address this gap, we propose a Phase IIa randomized, placebo- controlled trial of 140 WWH in Kenya to investigate an affordable, self-administered medical therapy as adjuvant treatment following thermal ablation to improve precancer treatment outcomes in WWH.